Training Program in Hematology

PROJECT SUMMARY/ABSTRACT
The primary objective of the Training Program in Hematology, in its 35th year of funding, is to train MD, MD/PhD,
and PhD postdoctoral fellows interested in adult hematology for careers in academic medicine and biomedical
research. Johns Hopkins Hematology is among the largest free-standing adult hematology programs. We are
requesting support for four postdoctoral trainees per year, which is unchanged from the previous grant cycle.
The Johns Hopkins Hematology Fellowship Program, which supports 2 single-board hematology fellows per
year, is the major substrate for this T32. This fellowship program is one of only 2 programs in the United States
that recruits for single-board hematology fellows, and provides dedicated training in benign and malignant
hematology without training in solid tumors. Thus, the purpose of the proposed training program is to prepare
qualified individuals with an MD and/or PhD degree for a research career in the field of adult hematology. The
training program consists of well-funded and highly experienced investigators, most of whom are internationally
recognized for their research pertaining to hematopoiesis and stem cell biology, anemias, hemoglobinopathies,
thrombotic microangiopathies, bone marrow failure states and myeloproliferative diseases. Training is enhanced
by an outstanding research environment with state-of-the-art research facilities and cores, outstanding faculty
mentors, and an existing program project grant on bone marrow transplantation. Despite a national trend away
from single board hematology fellowship programs, Johns Hopkins continues to attract outstanding MD and
MD/PhD candidates for single board hematology training and prepares them for careers in biomedical research1.
There is also an exceptional pool of PhD postdoctoral fellows from the labs of our basic science mentors who
are well-integrated in the hematology multidisciplinary conferences and even the clinical training program.
Specific aims are of this training program are:
1) to provide research training opportunities in a variety of areas pertaining to hematology including benign and
malignant hematopoiesis, bone marrow failure disorders, bone marrow transplantation, stem cell biology,
immunology, genetics, thrombotic microangiopathies, myeloproliferative/myelodysplastic syndromes and
hemoglobinopathies
2) to provide the opportunity for structured coursework and seminars pertaining to clinical, translational and basic
research pertaining to hematology, and to provide opportunities for instruction in grant writing, manuscript
writing, public speaking and biostatistics
3) to allow for group mentoring, and careful monitoring of the trainees’ progress and the overall success of the
training program
4) to address the critical shortage of adult hematologists pursuing careers in academic hematology

Public health relevance
PROJECT NARRATIVE The goal of this Program is to attract and to train exceptional postdoctoral fellows for careers in academic adult hematology. Improved understanding of the underpinnings of stem cell biology, hemoglobinopathies, thrombotic microangiopathies, bone marrow failure states, and myeloproliferative diseases will aid in translating laboratory findings into novel clinical therapies.